Characterization of a novel spinal astrocyte-neuron signaling system in chronic pain

Project Summary/Abstract
Chronic pain affects 20% of the U.S. population, poses an enormous socioeconomical cost and remains an
area of considerable unmet medical need. The opioid epidemics added urgency to develop novel and
actionable therapeutic targets. We have identified a novel intercellular signaling system in spinal cord involving
the multifunctional enzyme CD38 that may inform the development of new-generation analgesics and help
solve this critical void. CD38 was first identified as an immune cell marker and is now widely recognized as a
multifunctional enzyme that regulates cellular responses to chemical cues via the metabolism of nicotinamide
adenine dinucleotide (NAD) into multiple mediators of calcium signaling. Using genetic and pharmacologic
methods in mouse models of neuropathic and inflammatory pains, we generated evidence suggesting that
CD38 expressed in astrocytes is part of an endogenous anti-nociceptive system in the spinal cord that is
relevant to chronic pain. There is, therefore, a critical need to fully characterize and validate the role of CD38
and its metabolites in reducing hypersensitivity associated with peripheral nerve injury and inflammation. Our
long-term goal is to understand the mechanism by which CD38 influences nociceptive signaling to develop
novel pain therapies. Our overall objective in this application is to characterize how CD38 expression in the
spinal cord mediates anti-nociception in mouse models of neuropathic and inflammatory pains. Our central
hypothesis is that CD38-dependent signaling in the spinal cord can decrease hypersensitivity associated with
peripheral nerve injury and inflammation. The rationale for the proposed studies is that characterizing the
CD38 anti-nociceptive signaling could lead to novel therapeutic developments for chronic pain. In the absence
of such knowledge, the realization of a CD38-centered strategy to treat chronic pain will remain uncertain. The
following two specific aims will be pursued: 1) Validate CD38 as a target for opioid signaling in neuropathic and
inflammatory pain models. 2) Characterize the anti-nociceptive properties, tolerance and reward liability of
CD38-generated metabolites in neuropathic and inflammatory pains. For the first aim, we will use an integrated
genetic and pharmacologic strategy in distinct pain models (spared nerve injury, SNI; complete Freund’s
Adjuvant, CFA) to understand the role of CD38 in opioid signaling in the spinal cord. Under the second aim, we
will use CD38-generated metabolites alone or in combination with opioids in the CFA and SNI pain models to
determine the anti-nociceptive properties of the metabolites. The proposed exploratory research is innovative
because it focuses on a novel endogenous antinociceptive spinal mechanism relevant to chronic pain with the
advantage of improved authentication of pharmacological tools. The research is significant because it is
expected to advance the mechanism-based understanding of spinal opioid signaling in neuropathic and
inflammatory pains, and provide strong evidence-based proof of principle for further developments of CD38-
based strategies for the treatment of chronic pain.

Public health relevance
Project Narrative The proposed research is relevant to public health because chronic pain is a common and socioeconomically very costly condition, for which currently available therapies are not sufficiently efficacious and/or safe. Preclinical mechanistic evidence of a novel endogenous antinociceptive signaling system in the spinal cord would support subsequent developments towards novel therapies for chronic pain. The proposed research is relevant to the part of the NIH mission pertaining to seeking fundamental knowledge about the nature and behavior of living systems and applying that knowledge to reduce illness and disability.